Determinants of cell type-specific vulnerability in Huntington's disease

Challenge and Impact: Huntington's disease (HD) is a fatal inherited neurodegenerative disease, and all cases are caused by CAG trinucleotide repeat expansions in the huntingtin gene. There are currently no curative therapeutics for HD, and thus there is a critical need for the development of new therapeutic targets. Striatal medium spiny neurons (MSNs) are thought to be the most affected neuronal cell type in HD, but it is still not fully understood how huntingtin mutation leads to neuronal cell death in general or MSNs in particular. Mutant Huntingtin protein (mHTT) is expressed fairly ubiquitously, suggesting that MSNs possess vulnerability factors or else lack protective factors. If these factors were known, they would advance mechanistic understanding and point to new HD therapeutic targets. One prominent hypothesis is that huntingtin mutation leads to a toxic gain-of-function dysregulation of gene expression. Many studies have used gene expression profiling to study transcriptional dysregulation and its mechanistic basis in HD, but to date these studies have been limited by anatomical cellular intermixing and thus have not detected genome-wide MSN cell type- specific changes to gene expression due to signal averaging across cell types. However, such data are necessary to fully understand whether transcriptional dysregulation is causative or a consequence of mutant Huntingtin (mHTT) toxicity, and whether MSNs possess distinct vulnerability factors or lack protective factors either intrinsically or in response to mHTT. The studies outlined in this proposal will advance mechanistic understanding and point to new therapeutic targets for HD. Approach: To perform cell type-specific gene expression studies, we have begun to apply the translating ribosome affinity purification (TRAP) methodology to the study of mouse models of HD. TRAP reports on the cell type-specific translatome, by allowing cell type-specific translated mRNA immunoprecipitation. Our preliminary HD model TRAP studies have identified a large number of previously uncharacterized changes to mRNA translation at an early, pre-symptomatic HD mouse model timepoint, and point to early dysregulation of forkhead box O1, Foxo1, transcription factor activity in MSNs in response to mHTT. In Aim1, we will perform cell type-specific TRAP analyses to investigate pre- and post-symptomatic gene expression changes in mouse models of HD to examine whether MSNs possess distinct HD vulnerability factors or lack HD protective factors either intrinsically or in response to mHTT. In Aim 2 we will determine the cell type-specific phosphorylation status, subcellular localization, and transcriptional targets of Foxo1 in MSNs, and how these are altered in HD model mice. In Aim 3 we will test the phenotypic effects of Foxo1 loss and overexpression in wildtype mice and HD model mice. If successful, the results of this aim will demonstrate a role for Foxo1 in causing enhanced vulnerability to mHTT, and thus provide proof-of-principle data that points to a novel therapeutic target pathway for HD.

Public health relevance
Huntington's disease (HD) is a devastating neurodegenerative disease for which there is no cure. A better understanding of the molecular mechanisms underlying this disease will lead to better therapeutic targets. The goals of this project are to perform cell type-specific gene expression studies in the most vulnerable cell types in HD, to understand the cell type-specific regulation and gene expression targets of Foxo1, and to test the necessity and sufficiency of Foxo1 in causing enhanced neuronal cell vulnerability in HD.